Research Project 2

Cervical cancer is the leading cause of cancer-related deaths among women in low and middle-income countries
(LMICs) and a key contributor to global disparities in cancer incidence and mortality. The WHO recommends
Human Papillomavirus (HPV)-based testing followed by immediate treatment, known as screen-and-treat (SAT).
Although endorsed in global and national guidelines, the SAT approach has not yet been widely implemented
outside of research settings. New technologies such as the Xpert HPV DNA test, a point-of-care (POC) test
which has distinct advantages over competing assays and has been shown to be cost-effective in low-resource
settings, is also more expensive. Like many countries, South Africa is grappling with how to operationalize and
promote the widespread and equitable uptake of HPV-based screening. Through a 30-year collaboration
between investigators at Columbia University and the University of Cape Town, and leveraging Project 1’s
development and evaluation of strategies for the implementation and evaluation of Xpert HPV POC-SAT, this
Project 2 of the Empilisweni Center for Women’s Health will address the cost and financing of POC-SAT and its
tailored implementation strategies. In Aim 1, using a comprehensive tool from the WHO, we will estimate costs
of cervical cancer screening pre and post implementation of HPV-based POC-SAT in public primary care settings
in Khayelitsha. Outcomes will be cost per woman screened and cost per woman screened and treated. In Aim
2, we will conduct a time-and-motion study to estimate the costs of the scalable, tailored implementation strategy
package to support delivery of POC-SAT in two primary care facilities implementing Aim 3 of Project 1. In Aim
3, we will use a fiscal mapping process to identify, select, and pursue innovative financing strategies for HPV-
based SAT and its implementation in Western Cape. Cost data collection will be conducted in coordination with
the Capacity Building and Stakeholder Engagement Cores to translate knowledge needs and study findings,
where applicable. We will further synergize activities by leveraging the routine Administrative and Engagement
Core stakeholder meetings and External Advisory Panel to brief stakeholders before and after cost data
collection, analysis, and reporting. The findings of this project will be disseminated to local and regional
stakeholders in order to aid decision-making regarding investments in cervical cancer screening and advance
the widespread use of HPV-based SAT in South Africa.